The role of non-classical MHC class I molecules in immune responses to Mycobacterium tuberculosis infection

PROJECT SUMMARY
While current Mycobacterium tuberculosis (Mtb) vaccine development has primarily focused on CD4+ and MHC
Ia-restricted CD8+ T cell responses, increasing evidence shows that non-conventional CD8+ T cells restricted by
MHC Ib molecules can recognize diverse microbial antigens and contribute to protection against Mtb infection.
For example, H2-M3, Qa-1/HLA-E, Qa-2/HLA-G, MR1, and CD1 have been implicated in the host immune
response against Mtb in mice and/or humans. However, most of these studies have only examined the function
of MHC Ib-restricted T cells during the primary response to Mtb infection. Given that several subsets of MHC Ib-
restricted T cells exhibit "innate-like" T cell characteristics and undergo unique thymic selection, it is unclear
whether and which MHC Ib-restricted CD8+ T cell population can mount a memory response during Mtb infection.
Furthermore, some MHC Ib molecules also act as regulators of the immune responses aside from their role in
antigen presentation. In particular, Qa-1 can regulate immune responses against Mtb through the interaction
with inhibitory CD94/NKG2A receptors and regulatory CD8+ T cells. To better understand the diverse role of
MHC Ib molecules play in immune responses against Mtb, this proposal seeks to determine whether the
composition and function of MHC Ib-restricted CD8+ T cell subsets in the secondary response differs from the
primary response, as well as how individual Qa-1-mediated regulatory mechanisms contribute to the immune
response against Mtb. In Aim 1, we propose to compare the kinetics, function, and protective ability of MHC Ib-
restricted CD8+ T cell responses during primary and secondary Mtb infection in mice, and evaluate the protective
efficacy of vaccination with Qa-1/HLA-E-restricted Mtb peptides. We will use a novel vaccination and re-
challenge model that allows for complete clearance of an attenuated Mtb strain prior to challenge with fully
virulent Mtb to study memory responses. These studies will allow us to identify the dominant MHC Ib-restricted
CD8+ T cells and the Mtb antigens they present during the secondary immune response, their ability to mediate
protective immunity against Mtb, and peptide vaccination strategies to increase the frequency of these effector
CD8+ T cells. In Aim 2, we propose to investigate the mechanisms by which Qa-1 regulates immune responses
during Mtb infection, with a focus on how inhibitory CD94/NKG2A receptors and suppressive Qa-1-restricted
CD8+ Tregs individually contribute to the regulation of T cell responses during Mtb infection. To study these
mechanisms, we will use mouse strains with genetic interruption of Qa-1’s interaction with individual receptors.
These studies will allow us to identify how Qa-1 is able contribute to the balance between effector and regulatory
immune responses for better protective immunity against Mtb. The combined results from our studies will yield
a better understanding of how MHC Ib molecules and MHC Ib-restricted T cells contribute to the overall immune
response against Mtb, for the development of better future vaccine strategies.

Public health relevance
PROJECT NARRATIVE MHC class Ib molecules play an important role in the immune response against Mycobacterium tuberculosis (Mtb), the causative agent of tuberculosis. This study proposes to use novel animal and bacterial models to examine the function of various MHC Ib T cell memory responses following vaccination. We will also examine the role of MHC Ib molecules in regulating the immune response against Mtb. Such studies may lead to identification of new targets and strategies for T cell based vaccines against mycobacterial infection.